CAP Funding in Support of Ongoing NC State Vet-LIRN Activities

PROJECT SUMMARY
The FDA Vet-LIRN program and the North Carolina State University (NCSU) College of
Veterinary Medicine share an important overarching mission to promote animal and
human health and well-being. As part of our mission, the NCSU College of Veterinary
Medicine houses the NC State Veterinary Hospital (VH), a state-of-the-art referral
veterinary medical center. The NCSU VH has existing laboratory facilities that provide
primary diagnostic support services for the nearly 36,000 patients seen by the VH each
year. These laboratories, Clinical Pathology and Immunology, Clinical Microbiology and
Molecular Diagnostics, Histopathology, and Necropsy Services, have been coordinated
and accepted to participate in the Vet-LIRN program as a Tier 1 laboratory. As such, the
NCSU VH laboratories can serve as a resource for surveillance and emergency
outbreak veterinary diagnostic analysis of pathological, microbiological, or chemical
agents as directed by the Vet-LIRN program office and in coordination with NCSU
program management. Our facilities, resources, and personnel expertise will be useful
in the event of a large-scale food/drug emergency. By participating in the program we
are contributing to the NCSU College of Veterinary Medicine mission, as well as the
mission of the Vet-LIRN program to provide scientific information, build laboratory
capacity, and train scientists. Our aim is to establish a cooperative agreement with the
FDA's Vet-LIRN program so that we can ensure our laboratories have the infrastructure
and capacity to best respond to any Vet-LIRN program request. In addition, a
cooperative agreement will allow our laboratories to plan and participate in laboratory
training exercises, such as proficiency testing, to ensure appropriate methods and
quality control management techniques are used in the case of an event. We will also
provide isolate and metadata for completion of the Vet-LIRN sequencing project. The
NCSU VH laboratories are committed to and will be actively engaged in the need of the
Vet-LIRN program.

Public health relevance
PROJECT NARRATIVE The FDA Vet-LIRN program and the North Carolina State University College of Veterinary Medicine share an important mission to support and promote animal and public health and well-being. By working together to provide diagnostic support services, surveillance testing, and method development and validation, we can help promote and secure public health through testing for chemical, pathological, and microbiological agents and processes associated with animal and or zoonotic disease.